Identification and characterization of a comprehensive set of factors required for sporulation and germination in Bacillus anthracis

PROJECT SUMMARY/ABSTRACT
Bacillus anthracis spores are the infectious particles for the disease anthrax. Through abrasion, ingestion, or
inhalation, spores access subcutaneous layers, gastrointestinal mucosa, or alveolar cavities where they are
phagocytosed by macrophages, undergo germination, and cause cutaneous or systemic disease. While spores
are required for transmission, their germination and outgrowth are critical for pathogenesis. However, owing to
poor survival as vegetative cells in the environment, the cycle of germination, vegetative growth, and spore
formation is essential for the pathogenic lifestyle of B. anthracis. Environmental changes due to global warming
and deforestation have increased seasonal anthrax outbreaks in endemic areas and have led to the emergence
of new zoonotic pathogens. Addressing these challenges will require a deeper understanding of the mechanisms
of B. anthracis sporulation and germination. Targeting these processes will facilitate the development of
strategies for more effective disease prevention and treatment.
For years, the non-pathogenic soil bacterium Bacillus subtilis has served as the model for sporulation and
germination of spore forming pathogens like B. anthracis. Only a handful of factors involved in these processes
have been characterized in B. anthracis; in all cases these were homologs of B. subtilis sporulation/germination
proteins. In preliminary studies, we used transposon sequencing (Tn-seq) to identify 156 sporulation genes in B.
anthracis. Strikingly, 77 of these genes are either not required for B. subtilis sporulation or are not present in its
genome. This grant proposal seeks to leverage modern molecular approaches to identify and characterize the
complete set of sporulation and germination factors in B. anthracis. The aims are:
(1) Characterize the complete set of B. anthracis sporulation factors. We will build an ordered library of Tn
insertions in all nonessential B. anthracis genes using the Knockout Sudoku method. We will then use individual
mutants to characterize all the sporulation genes we identified. We will perform quantitative sporulation assays
and fluorescence microscopy to determine the stage at which development is blocked. Finally, we will initiate
molecular characterization of those factors that have strong mutant phenotypes and are unique to B. anthracis.
(2) Identify and characterize a comprehensive set of germination factors in B. anthracis. We will perform
a complementary germination Tn-seq screen in B. anthracis that we have successfully performed in B. subtilis.
Using the ordered knock out collection, we will then validate the hits and characterize those with the strongest
germination defect that are unique to B. anthracis.
If successful, this proposal will establish the extent to which B. subtilis can serve as a model for sporulation and
germination in B. anthracis and will define a large set of factors unique to processes in this pathogen that will be
subjected to mechanistic study. Finally, the ordered knockout library we describe will be made available to the
scientific community and will catalyze research in all areas of B. anthracis biology.

Public health relevance
NARRATIVE Spore formation and spore germination are central to the transmission and pathogenesis of Bacillus anthracis, yet our understanding of these processes are derived almost exclusively from work in the non-pathogenic model Bacillus subtilis. A deeper understanding of the molecular mechanisms that underlie B. anthracis sporulation and germination will facilitate the development of strategies for more effective disease prevention and treatment.